Endothelial Smad3 as a Novel Target to Avert Chemotherapy Induced Cardiomyopathy

PROJECT SUMMARY / ABSTRACT
Due to advances in early detection, improved therapies and supportive care, cancer survival rates have
increased substantially over the past decades. This success translates into a rapidly increasing number of cancer
survivors who suffer from cardiovascular complications of anticancer therapy. Of particular concern are
doxorubicin and other anthracycline drugs that are used to treat hematological malignancies, breast, ovarian,
and other solid tumors. Patients treated with these drugs suffer from long-term cardiac damage and remodeling
known as doxorubicin cardiomyopathy. Most studies have focused on cardiomyocytes as a direct target of
doxorubicin. We have recently shown that microvascular endothelium is a critical target of doxorubicin in the
heart. Specifically, we detected an altered pattern of endothelial gene expression and adverse cardiac
remodeling that persisted after completion of the doxorubicin treatment and was mediated by the canonical TGF-
beta pathway. While we have established involvement of the TGF-beta/Smad3 pathway in endothelial damage
by doxorubicin, the downstream processes remain unknown. Additionally, most of experimental studies on
doxorubicin cardiotoxicity have been performed on male animals and sex-specific differences in prevalence and
mechanisms of cardiomyopathy have not been adequately addressed. We propose to test a hypothesis that
doxorubicin promotes endothelial reprogramming via upregulation of the TGF-beta/Smad3 pathway, and
suppression of Smad3 transcriptional activity in endothelial cells will alleviate endothelial reprogramming and
cardiomyopathy in doxorubicin treated animals. Specific Aim 1 is designed to assess the role of the TGF-
beta/Smad3 pathway in endothelial-to-mesenchymal reprogramming by doxorubicin in female and male
endothelia. We plan to utilize Smad3 deficient human endothelial cell lines and transgenic mouse strains to
examine the role of this pathway in both activation of the mesenchymal/profibrotic program and suppression of
endothelium specific transcription by doxorubicin. In Specific Aim 2, we propose to examine the role of
endothelial Smad3 in promoting adverse cardiovascular remodeling and dysfunction in doxorubicin treated
female and male mice. While our prior studies utilized a model of global Smad3 knockout, we have now
generated a novel transgenic strain featuring an endothelial Smad3 knockout that will enable us to directly
address the role of cardiac endothelial cells in doxorubicin cardiomyopathy. We propose to utilize a clinically
relevant model of doxorubicin cardiomyopathy in female and male mice that will allow us to evaluate the role of
endothelial Smad3 in sustained endothelial dysfunction, microvascular remodeling, and depressed cardiac
function. Students at the Colleges of Osteopathic Medicine and Biosciences at KCU will be involved in the
proposed research project. We anticipate that the proposed approach will help develop novel vasculature
targeted therapies to preserve endothelial resiliency and prevent cardiac remodeling and progression of
cardiomyopathy.

Public health relevance
PROJECT NARRATIVE Increasing numbers of cancer survivors suffer from “collateral” damage to the heart as a result of chemotherapy. Precise mechanistic understanding and specific therapies of cardiovascular complications of chemotherapy are lacking. The project is designed to identify novel approaches to avert cardiovascular damage by chemotherapeutic drugs and ultimately improve quality of life of cancer survivors.